Personalized Therapies of Pediatric Sepsis

PROJECT ABSTRACT
Sepsis is a life-threatening condition characterized by a dysregulated response to infection, leading to
significant organ dysfunction and affecting 75,000 children and one million adults each year. The estimated
yearly impact of this disease is 200,000 lives lost and $20 billion dollars in healthcare expenditures.
Unfortunately, many initially promising sepsis therapeutics have failed to show wide benefit with tested in wider
clinical trials. However, post-hoc analyses of some of these therapeutics demonstrate benefit to specific
subgroups, raising concern that failure of sepsis therapeutics have failed due to the one-size-fits-all approach
employed in clinical trials. It is now widely accepted that sepsis represents a heterogeneous group, likely with
subtypes that are expected to respond differently to various treatments. Multiple efforts have been made to
characterize this heterogeneity, though few of these have been in pediatric patients. Moreover, phenotyping
efforts have typically relied on point measurements in time, including for vital signs. However, the ICU provides
a wealth of continuously measured vital sign data, including high-frequency physiologic data, that may offer
insights into underlying physiologic derangements and augment sepsis subtypes. Moreover, this type of data
may provide evidence in real time of developing infections prior to the onset of more classic signs such as
fever. Such insights have already been demonstrated in neonatal patients. The overarching goal of this study is
to develop personalized sepsis therapeutics by developing predictive tools based on integrating high-frequency
physiologic data with electronic health record data. Aim 1 focuses on augmenting sepsis phenotypes through
the inclusion of high-frequency data. This data is expected to identify additional subtypes or aid in prediction of
disease progression after day 1. Aim 2 aims to first retrospectively identify signs of bloodstream infection (BSI)
prior to traditional diagnostic signs and develop predictive algorithms based on these signs. The algorithms will
then be externally validated using the multicenter CHoRUS database. Aim 3 involves a real-time evaluation of
BSI prediction algorithms by silently implementing (i.e. without alerts) the best performing model in the
investigator’s hospital. This will permit fine-tuning of the model and real-world evaluation. This work will
significantly enhance our ability to predict, treat, and potentially even prevent sepsis by early identification of
BSI, improving outcomes for pediatric patients. This research will occur within the context of a career
development plan under the guidance of a multidisciplinary team with expertise in critical care, infectious
diseases, machine learning, and informatics. The coursework laid out will provide additional skills necessary to
conduct the proposed research and future endeavors, and the proposed research will provide the foundation
for future work developing and implementing predictive analytic tools to treat and prevention severe infections
in children.

Public health relevance
PROJECT NARRATIVE This research aims to enhance the detection and treatment of sepsis in pediatric patients by integrating high-frequency physiologic data with electronic health records. By identifying more accurate sepsis phenotypes and predicting bloodstream infections earlier, the study seeks to improve patient outcomes, reduce complications, and lower healthcare costs. Ultimately, this work will contribute to fundamental knowledge in pediatric critical care and infectious diseases and facilitate the development of personalized therapeutic strategies in critically ill children.